An innovative telomerase-targeted, circulating tumor cell assay for monitoring NSCLC treated with radiation and immunotherapy

Project Summary:
Cancer is a leading cause of death both in the United States and across the world, claiming over 600,000 and 8
million deaths each year, respectively. Delayed detection of cancer progression or recurrence after treatment
contributes to increased morbidity and rapid death, but re-biopsy or repeat surgery is usually not possible due to
severe risks. The accuracy of conventional imaging modalities for timely detection is limited, especially after
radiation- and immunotherapy, when treatment-induced edema/ inflammation mimics cancer progression. Thus,
there is an urgent need for safe, reliable, and non-invasive serial biomarkers (“liquid biopsies”) that provide “real-
time” information of the status of a wide range of solid cancers. Liquid Biotech has collaborated with academia
and NRG cancer cooperative group to develop the TelomeScan circulating tumor cell (CTC) assay for fulfilling
these unmet needs. TelomeScan has unique advantages including the detection of elevated telomerase activity
(which contributes to immortality and is a hallmark of cancer) in live cancer cells (the component of tumors that
most directly lead to tumor progression and metastasis), and imperviousness to the epithelial-mesenchymal
transition (EMT) that frequently occurs in cancer. TelomeScan has consistently shown it can detect cancer
recurrence in patients with non-small cell lung cancer (NSCLC) six months to 2 years before conventional
diagnostic imaging, thus providing valuable lead-time for actionable therapeutic intervention while minimizing
unintended side effects and cost of treatment that is no longer effective. Liquid Biotech has continued upon these
efforts by providing availability of the assay in a centralized laboratory for multi-center clinical studies. We are
currently near completion on two additional clinical trials, including for NSCLC in collaboration with NRG
Oncology. The goal of this project is to develop TelomeScan into a commercially available product that can
benefit a broader range of patients. Aim 1 will develop a clinical prototype for the TelomeScan test incorporating
automated analysis to handle substantially higher volumes of samples, thus expanding access and cancer
coverage. Aim 2 will develop the quantification of PD-L1 staining in TelomeScan identified NSCLC cells and
CTCs, by monitoring pre- and post-treatment samples from patients undergoing or eligible for radiation and
immunotherapy. These aims will lead to expanded access to benefit a far greater number of patients with NSCLC
and other cancers (Phase II).

Public health relevance
Project Narrative Cancer is a leading cause of death and suffering in the United States and worldwide, and cancer recurrence or progression after treatment, or unintended side-effects and complications resulting from treatment that is no longer effective, can both contribute to suffering and early demise. Detection of rare cancer cells in circulation via a routine blood draw is called a “liquid biopsy,” and can inform early intervention or change of treatment to a more effective form, while avoiding harm and costs from ineffective treatment; TelomeScan is a unique liquid biopsy assay that specifically detects circulating cancer cells (CTCs) by an elevated telomerase activity signature, characteristic of nearly all types of cancer but not normal cells. The development of TelomeScan into an effective commercial product could greatly aid the treatment and management of a wide variety of solid cancers (such as lung cancer) and help cancer patients worldwide, enhancing treatment success and patient survival while minimizing unnecessary harm and costs of ineffective treatment.